Predicting Relapse at the Time of Diagnosis in Acute Lymphoblastic Leukemia

PROJECT SUMMARY
Relapse is the major cause of cancer related mortality in children with leukemia. Despite improvements
in overall survival for children with B-cell progenitor acute lymphoblastic leukemia (ALL), for the 600 patients
who will relapse each year, half will die of their disease. The high mortality of patients who relapse underscores
the need for improved risk prediction and treatment strategies to prevent recurrent leukemia. Current
approaches to relapse prediction are limited by insufficient accuracy, delayed prediction and the inability to
make actionable treatment adjustments based on prediction information. To address these limitations, we
applied a single-cell, high-parameter proteomic approach to ALL patient samples at the time of diagnosis,
accurately predicting future relapse based on the presence of pre-B cells with activated signaling. This
approach was 38% more accurate than standard of care relapse prediction methods. We propose that
identifying relapse-predictive cells in ALL at the time of diagnosis using their distinguishing proteomic
and genetic features will result in a clinical risk prediction model that is accurate, immediate, and
actionable. This approach to relapse prediction will change the clinical paradigm of relapse risk in ALL to
reduce the incidence of relapse itself.
Using large multi-institutional, multimodal cohorts of molecularly and clinically annotated diagnostic
patient samples, we will apply deep proteomic approaches to identify surface proteins uniquely expressed on
relapse predictive pre-B cells enabling direct identification in a diagnosis sample. We will determine how
genomic mutations associate with the presence of relapse predictive cells and examine their genomic
mutational burden using single-cell exome sequencing. Finally, building on our data-driven, machine learning
approaches, we will construct a diagnostic relapse predictor that is more accurate than standard of care
models while informing on leukemia biology and targeted therapeutic options for patients at risk. This will
enable a more precise approach to patient classification and treatment, reducing the number of children facing
relapse and moving closer to precision medicine for children with ALL.

Public health relevance
PROJECT NARRATIVE Relapse remains a leading cause of death for patients with B-cell acute lymphoblastic leukemia. Using single- cell studies of primary diagnosis samples from patients, we can identify cells responsible for future relapse at the time of diagnosis. Building a model of relapse risk prediction based on the presence of these cells will enable rapid, accurate, and actionable relapse prediction moving closer to the goal of preventing relapse.